Core B: MPN-RC Tissue Bank

Core B Abstract
Core Lead: Bridget Marcellino, MD, PhD
Core B, Tissue Bank provides the infrastructure to transport, receive, process, store, and distribute tissue
specimens obtained from patients with myeloproliferative neoplasms (MPN) enrolled on the longitudinal tissue
bank as well as patients enrolled on clinical trials (Project 4). These specimens are provided to MPN-RC
investigators performing translational research for the purpose of developing innovative therapies (Projects 1-3).
They are also provided to the Biomarker and Bioinformatics Core D to perform biomarker analyses to evaluate
the effectiveness or causes of resistance of specific therapies being evaluated to deplete MPN hematopoietic
stem and progenitor cells. Tissues are also available to members of the scientific community at large for
translational research. Translational research is dependent on the ready availability of tissues from a sufficient
number of accurately diagnosed patients to generate statistically significant data. Because the MPNs are
relatively uncommon and their accurate diagnosis can be difficult, there has been a paucity of tissue, linked to
clinical data, available to individual investigators at single institutions. Core B fills this void. With an inventory of
specimens from more than 1700 individual patients with MPNs, Core B maintains one of the world’s largest
inventories of MPN tissues available for research. In addition, Core B collects specimens from patients
participating in MPN-RC sponsored clinical trials (Project 4) for the purpose of performing biomarker studies to
demonstrate the effectiveness of specific therapies on the depletion of MPN hematopoietic stem and progenitor
cells. The specific aims of Tissue Bank Core B are the following: (1) Receive, process, cryopreserve, and store
tissues from MPN patients participating in a longitudinal tissue bank (MPN-RC 106) as well as patients enrolled
on clinical trials (Project 4) at MPN-RC clinical sites. (2) Provide a central repository for MPN tissues that are
associated with clinical and mutational annotation data stored in the web-based data bank maintained by
Biostatistics and Data Management Core C. This annotation, selection and distribution of tissues is tailored for
each translational research project. (3) a. Distribute tissues to MPN-RC investigators and the larger scientific
community for translational research dedicated to elucidating the mechanisms driving the pathogenesis and
progression of MPNs and developing novel therapeutic strategies to target MF stem cells. b. Distribute clinical
trial specimens to analyze on-target effects of novel agents and create biomarkers which will determine
therapeutic and pharmacodynamic responses to therapy (Core D). Core B is an essential shared resource that
enables translational research that will ultimately lead to the development of therapies, which target the MPN
stem cell.

Public health relevance
Core B Project Narrative The Core B Tissue Bank is an essential resource of the Myeloproliferative Neoplasms-Research Consortium (MPN-RC) which receives, processes and stores tissues collected from MPN patients consented under IRB approved Protocol 106 (Project 4), as well as patients on Project 4 clinical trials. Core B provides a central repository for these tissues that are associated with clinical and mutational annotation (Core C), which enables appropriate selection of specimens for each project. Specimens are distributed to MPN-RC investigators and the larger scientific community for translational research and clinical trial specimens are utilized for biomarker and pharmacodynamic analysis of novel therapies (Core D).